Modulating Exercise Dosage to Improve Concussion Rehabilitation: A Randomized Clinical Trial

Project Summary
Concussions are defined as a mild form of traumatic brain injury that result in acute neurological dysfunction.
Recent work suggests post-concussion aerobic exercise at an intensity level below symptom exacerbation is
safe. Yet, clinical benefits from existing randomized controlled trials indicate substantial room for improvement.
Also, we currently have an incomplete understanding of the neurophysiology underlying changes in response to
exercise treatment. Identifying the precise exercise dose (volume/intensity) required to elicit a therapeutic
response following concussion will lead to enhanced and more precise post-concussion rehabilitation strategies.
Our published and pilot data indicate light post-concussion exercise was associated with faster symptom
resolution time and less severe symptoms, yet we relied on self-reported data and observational designs.
Furthermore, we have identified that the optimal exercise volume to differentiate those with/without concussion
symptoms after one month was >160 minutes/week, which is higher than standard exercise volumes prescribed
(>100 minutes/week), and in line with existing recommendations for cardiovascular health (>150 minutes/week).
Beyond this, given the positive effects of regular moderate exercise to reduce inflammation (e.g., interleukin 6)
and restore cerebrovascular regulation, these physiological functions represent viable and feasible rehabilitation
targets. Thus, using a prospective randomized clinical trial design, we aim to identify if high dose exercise >(150
minutes/week at an individualized intensity level), relative to standard-of-care, results in: faster/slower symptom
resolution, altered physiological function, or reduced secondary sequalae. Our multidisciplinary investigative
team has expertise investigating concussion, exercise physiology, fluid biomarkers, cerebrovascular physiology,
and psychosocial outcomes. Thus, we will enroll, initially test, and randomize adolescents ages 13-18 years old
≤10 days post-concussion to high dose aerobic exercise or standard-of-care (symptom limited, self-guided
physical activity), and reassess upon symptom resolution and 8-weeks post symptom resolution. We will obtain
cerebrovascular function and serum biomarker data at each visit, and quantify exercise, symptoms, and
secondary sequalae continuously. First, we aim to examine how the dose (intensity, duration, and frequency) of
an aerobic exercise program initiated within 10 days of concussion affects time to symptom resolution, relative
to standard-of-care, among adolescents. Second, we aim to assess the mechanistic relationship between
aerobic exercise, biomarkers of neuroinflammation, and cerebrovascular function. Third, we aim to elucidate
how high dose exercise after concussion affects persistent secondary sequalae development (anxiety,
depression, kinesiophobia, peer relationships, academic concerns). By challenging the currently accepted,
exercise recommendations for sport-related concussion, we will break new ground toward improving
rehabilitation strategies.

Public health relevance
Project Narrative Aerobic exercise has emerged as an effective treatment to reduce sport-related concussion symptom severity, yet existing work lacks rigor regarding the precise exercise volume and intensity required to elicit therapeutic effects, how exercise can alter concussion-related pathophysiology, and whether exercise can prevent the development of secondary sequelae. Our objective is to examine if a high dose exercise program (higher volume than currently prescribed at an individualized, safe intensity level) initiated within 10 days of concussion results in faster symptom resolution, altered physiological function, or reduced secondary sequalae. Findings from this research will lead to more rigorous and precise rehabilitation guidelines and improved understanding about how exercise affects neurophysiological function among adolescents with concussion.